Assessment of Biomarkers in Children to Help Parents Quit Tobacco

ABSTRACT: Tobacco use is the single greatest preventable cause of morbidity and mortality in the United
States, accounting for 480,000 deaths and $300 billion in attributable costs annually. One quarter of all
smokers are seen at their child’s primary care office and may not have a primary care doctor of their own.
When parents quit smoking, their life expectancy is increased by over 10 years, future tobacco-related poor
pregnancy outcomes are avoided, children have a four-fold lower risk of becoming smokers, the family has
more money for necessities, and children are less likely to suffer diseases caused by tobacco smoke exposure
(TSE). Routinely delivered tobacco control assistance to parents in the pediatric setting would provide a major
health benefit to the nation. Our previous systems change efforts using the Clinical Effort Against Secondhand
Smoke Exposure (CEASE) intervention to identify parents who smoke, deliver nicotine replacement therapy,
and enroll them in the quitline have shown significant improvements in pediatric practice uptake and parent
outcomes. However, the CEASE intervention has faced barriers, such as reliance on parental self-report of
TSE, which underestimates childhood exposure, and variable provider adherence to delivering parental
cessation assistance. Children who live with smokers are exposed to secondhand and thirdhand tobacco
smoke, and potentially to aerosol from parents who use electronic nicotine delivery systems (ENDS). Routinely
screening children’s blood for cotinine, a biomarker of nicotine exposure, could reliably identify children with
TSE exposure. Extant lead screening programs, already part of pediatric healthcare delivery, provide an
obvious, yet currently untapped opportunity to screen for cotinine at well-child visits. Routine cotinine
measurement in children using blood already collected for lead testing can institutionalize management of TSE
in a comparable fashion. Results from objective cotinine testing could be used to motivate both providers and
parents to promote tobacco control and cessation activities. Our preliminary qualitative and quantitative work
suggests this approach is feasible, acceptable, and effective. We hypothesize that providing cotinine biomarker
results to pediatricians, personalized cotinine feedback to parents about their child’s toxin exposure, and
offering support to all household tobacco users to quit tobacco use (Biomarker Informed Outreach (BIO)) when
added to the CEASE intervention will increase delivery of tobacco cessation assistance, increase household
cessation, reduce TSE in children, and be cost-effective. We propose a 2-arm RCT conducted in five pediatric
practices, enrolling children and parents at the child’s 1-year well child visit. The enrolled subjects will be
randomized to either CEASE+BIO or CEASE arms. To compare the effectiveness of CEASE+BIO vs. CEASE,
we will follow-up with enrolled parents at the 2-year well child visit to assess parental quit rate and children’s
TSE. Trial results could lead to universal documentation of TSE and trigger more effective tobacco cessation
support for the group of young adult parents who live with, expose, and influence the next generation.

Public health relevance
Project Narrative The objectives of this research are to improve the identification of children exposed to tobacco smoke, improve the delivery of parental tobacco control treatment in child healthcare offices, and in turn increase household cessation rates by testing the effectiveness of routinely screening children’s blood for cotinine, a biomarker of nicotine exposure, at the same time children are tested for lead. This innovative screening approach to detecting tobacco smoke exposure in children will provide cotinine biomarker results to pediatricians, send personalized cotinine feedback to parents about their child’s toxin exposure, and offer support to all household tobacco users to quit tobacco using trained tobacco cessation counselors to deliver Biomarker Informed Outreach (BIO). Data from this study will be used to measure how routinely screening children for cotinine and using BIO increases delivery of tobacco cessation assistance in child healthcare offices, improves household cessation rates, reduces tobacco smoke exposure in children, and if it is cost-effective compared to a tobacco control intervention that does not utilize routine cotinine measurement.